National Career Development Program for Researchers in Pediatric Clinical Pharmacology

ABSTRACT
The demand for pediatric clinical pharmacologists continues to grow, necessitating investment in career
development programs to train the next generation of pediatric clinical pharmacologists. This new K12
application seeks to establish the “National Career Development Program for Researchers in Pediatric Clinical
Pharmacology.” This program will combine faculty expertise, pediatric clinical pharmacology research programs,
and clinical research resources from a nationally dispersed group of leading academic institutions. The goal for
this national career development program is to enhance the existing training opportunities through the Eunice
Kennedy Shriver National Institute of Child Health and Human Development (NICHD) Pediatric Clinical and
Developmental Pharmacology Training Network (PCDPTN). Program faculty are grouped into three areas of
subject matter expertise: 1) Pharmacokinetics/Pharmacodynamics and Clinical Trials, 2) Pharmacoepidemiology
and Data Science, and 3) Translational Research. The program faculty are selected based on their outstanding
research accomplishments and track record mentoring junior investigators. In addition, the proposed career
development program will leverage resources provided by the Pediatric Trials Network (PTN), the Maternal and
Pediatric Precision in Therapeutics (MPRINT) Hub, and other NICHD-sponsored programs. The participating
institutions have outstanding research environments and a reputation for successful mentorship of junior faculty
pursuing academic careers in pediatric clinical pharmacology. Each scholar will complete a research project
within one of the theme areas for the career development program, and they will be matched with a primary
research mentor and a faculty mentoring committee. Scholars will be able to leverage faculty expertise across
the participating institutions for research and mentoring. In addition to the research project, scholars will complete
professional development opportunities, including training and mentorship in pediatric clinical pharmacology,
written and oral communication, methods for enhancing research reproducibility, and research ethics. An Internal
Advisory Board comprised of experts in pediatric clinical pharmacology will help with scholar selection,
developing strategic partnerships, and advising on program enhancements. In addition, an External Advisory
Board composed of experts in pediatric and maternal pharmacology and with extensive experience mentoring
junior faculty will meet annually with scholars and the Executive Committee and provide advice on the structure
and future directions for the program. The program will be evaluated by the External Advisory Board and through
scholar and mentor evaluations. This career development program will enable scholars to generate the
publication record, preliminary data, and skill set that is necessary to be competitive for independent research
grants. Following completion of the program, all scholars will be exceptionally well-positioned to pursue impactful
careers focused on promoting the safe and effective use of medications in children.

Public health relevance
NARRATIVE Due to an expansion in pediatric drug development research, there is an increasing need to train researchers with expertise in pediatric clinical pharmacology. This new application seeks to establish a “National Career Development Program for Researchers in Pediatric Clinical Pharmacology,” combining faculty expertise and resources across leading academic institutions with programs in pediatric clinical pharmacology. Upon completion of the career development training, scholars will be exceptionally well positioned to pursue impactful careers focused on promoting the safe and effective use of medications in children.